Donor Derived CD19/CD22 CAR T Cells as Concurrent Therapy Against Relapse in Adults with B-ALL

Abstract
Allogeneic hematopoietic cell transplantation (allo-HCT) is a potentially curative therapy for patients with
hematologic malignancies. Yet, relapse and graft versus host disease (GVHD) are the leading causes of
morbidity and mortality. Administering regulatory T cells (Tregs) with the allograft mitigates GVHD but relapse
remains a significant issue. Likewise, chimeric antigen receptor (CAR) T cell therapy has contributed to
substantial progress in the treatment of patients with hematologic malignancies, but 60% of patients treated with
CD19-targeting experience progressive disease. A clinical study of an autologous bispecific CAR targeting CD19
and CD22 (CD19-22.BB.z-CAR = CAR19/22) induced remission in patients with B-cell acute lymphoblastic
leukemia (B-ALL) (n=17), but a high rate of relapse was also noted in these patients (NCT03233854).
Preclinical and clinical data suggest that donor CAR T cells administered following allo-HCT induce less GVHD
compared to unmodified donor T cells. Hence, in a phase I, single center study we are investigating whether
relapse may be diminished in patients with B-ALL by combining Treg allo-HCT and donor CD19/CD22 CAR-T
cells (NCT05507827). Patients with B-ALL will receive an allo-HCT consisting of purified Tregs, CD34+
hematopoietic progenitor cells, and conventional T cells (Tcons) followed by a consolidative dose of donor
CAR19/22. Hence, we will utilize correlative studies from the phase 1 clinical study and a preclinical model
assess the following Specific Aims: (1) compare efficacy, toxicity, and pharmacokinetics of human donor
CAR19/22 with Treg allo-HCT in a phase 1 clinical trial relative to autologous CAR19/22 and allo-HCT alone, (2)
assess the impact of donor CAR19/22 on graft immune reconstitution, and (3) determine the effects of clonal
hematopoiesis (CH) mutations and lentiviral integrations among CD19/CD22 CAR T cells.
We anticipate that combining donor CAR19/22 with Treg allo-HCT will increase anti-tumor activity and decrease
relapse without causing GVHD. The clinical and correlative insights gained from the research proposed in Aims
1 and 2 will guide the use of combined cell therapies in diseases other than B-ALL. Moreover, the studies in
Aim 3 regarding CH in CD19/CD22 CAR T cells may identify unanticipated benefits for using donor cells in CAR
manufacturing.

Public health relevance
PROJECT 3: PROJECT NARRATIVE The proposed clinical research will provide novel insights regarding how allogeneic hemopoietic cell transplantation and chimeric antigen receptor T cell therapy can be combined to treat patients with hematologic malignancies at high-risk of disease relapse. The proposed research will combine cellular therapy, single cell sequencing, spatial and flow cytometry to interrogate the clinical outcomes and underlying mechanisms of therapeutic response with these combined modalities.